A Translational Research Approach to Healthy Technology Usage in Dual Language Families with Young Children

PROJECT SUMMARY
Technology use among young children in the U.S. has become increasingly prevalent over the past decade, and the increasing prevalence of online learning has renewed concerns among parents and educators about screen time. Recommendations for choosing high-quality apps and setting boundaries around device use are often conveyed through position statements, white papers, and blog posts, but the information is rarely presented in an engaging, family-friendly manner that can be readily adopted and sustained in young children’s everyday routines. This challenge is especially pronounced in households where a language other than English is spoken, as families may have difficulty finding and using available resources. This project delivers an interactive, dual language, hybrid virtual-and-physical world approach to address these translational gaps. It presents recommendations from the academic and medical spheres through storytelling and a suite of interactive, co-play activities in an online virtual world, then transitions the gameplay to caretaker-child interactions in the physical world, empowering users to first practice healthy technology through interactive online games and then implement those rehearsed practices in their day-to-day lives. The effectiveness of the online platform and interactive content will be evaluated through a randomized controlled study. Improvements in knowledge, attitudes, and confidence related to healthy technology use will be assessed among children and their caretakers. The platform will also be evaluated for its ability to facilitate dual language interactions between child and caretaker that support learning and language development. Overall, our product will serve not only as a means to inform families of best technology use practices, but as a catalyst to broaden and reimagine joint play with digital devices especially among dual language families.

Public health relevance
PROJECT NARRATIVE As highlighted in the NICHD strategic plan, technology use by children is a priority area for research as it impacts a child’s neurocognitive, behavioral, linguistic, and social-emotional outcomes. Despite ongoing efforts by medical associations and advocacy groups to provide up-to-date guidance, parents and educators continue to find it challenging to moderate children’s digital media consumption in a healthy way. This project addresses the growing need to make recommendations about healthy technology use actionable for families by using dual language storytelling, interactive games, and co-play in order to translate guidance into everyday routines.